A Drosophila Model for Behavioral Sleep Modification in Alzheimer's Disease

PROJECT SUMMARY Insomnia is the most common sleep disorder among older adults, affecting 50% of people over the age of 65. Among this older population, sleep disturbances are often the first presenting symptom of Alzheimer’s disease, as well as other forms of dementia. The link between sleep and Alzheimer’s disease is bidirectional: progression of disease is associated with worsened sleep, and poor sleep causes worsening cognitive function. Therefore, improving sleep has therapeutic potential in patients suffering from Alzheimer’s disease. Cognitive Behavioral Therapy for Insomnia (CBT-­I) is the first-­line therapy to treat sleep disturbances, but limited accessibility of practitioners and long duration of therapy are barriers that limit implementation. Hypnotic medications, a 2nd-­line insomnia treatment, are avoided in Alzheimer’s disease patients because they may exacerbate cognitive decline. With well-­validated models of chronic insomnia, aging, and Alzheimer’s disease, and unique genetic tools, Drosophila provides a dynamic system to investigate the underlying cellular mechanisms of behavioral sleep modification. I designed behavioral paradigms to model sleep restriction, one of the primary tenets of CBT-­I, in mutant flies that recapitulate the features of chronic insomnia. Sleep restriction in Drosophila is achieved by shortening the dark period from 12 to 4 hours, followed by sequential dark period expansion by 2 hours every other day. Preliminary data reveals that after sleep restriction, animals exhibit threefold increases in sleep efficiency and sleep consolidation. Thus, the central hypothesis of this proposal is that behavioral sleep therapy alters activity of sleep promoting centers, allowing for more efficient and consolidated sleep, which can be leveraged to produce sleep improvement in aging and Alzheimer’s disease models. This hypothesis will be pursued through 3 specific aims. Aim 1 will investigate how activity in sleep centers changes with sleep restriction, and which brain regions are necessary for improvements in sleep. Aim 2 will elucidate the effects of behavioral sleep modification on the aged brain. Aim 3 will analyze the change in behavioral and molecular outcomes with sleep restriction in a model of Alzheimer’s disease. Successful completion of these aims will elucidate the cellular mechanisms of behavioral therapy, validate sleep restriction as a therapeutic strategy for aging and Alzheimer’s disease, and serve as a foundation to search for molecular targets that can be translated into long-­term treatments for human patients.

Public health relevance
PROJECT NARRATIVE Sleep degrades with aging, and sleep disturbances are often the first clinical signs of Alzheimer’s disease. I will seek to reverse sleep fragmentation due to aging and Alzheimer’s disease through behavioral sleep modification in Drosophila. I will use this model system to provide a window into the cellular changes occurring with behavioral therapy, pioneering new sleep- based therapeutic strategies to ameliorate neurologic changes associated with aging and Alzheimer’s disease.